LEARN Science: A K-2 Life Science and Reading Program in Public Libraries to Improve Science Achievement through Storytelling

By third grade, poor science achievement among youth may pave their path to poor adult health, fewer employment opportunities, and lower economic mobility. LEARN Science – Library Efforts to Advance Reading and Nutrition Science – blazes a new trail for youth using informal science education (ISE) through community public libraries across Mississippi (MS). LEARN Science is a life science and reading program through a nutrition science lens to improve science achievement among children in kindergarten through 2nd grade (K-2). MS boasts a robust public library system. Public libraries are potential: 1) bridges to improve Science, Technology, Engineering, and Mathematics (STEM) opportunities; and 2) key collaborators for health education and promotion. The role of food for survival is a foundational scientific concept for children to learn in K-2. Food exposes youth to potentially dozens of scientific concepts daily, as well as to cultural traditions and health principles. As such, nutrition education can empower youth to make food choices for chronic disease prevention. Our overall long-term goal is to establish LEARN Science to improve science achievement among children in K-2. The program will be aligned with Next Generation Science Standards (NGSS) and be consistent with the social ecological model. LEARN Science will consist of seven lesson units. Each unit will follow a storyline and blend two age-appropriate books with: 1) nutrition science terminology; 2) inquiry-based, hands-on activities using science tools; 3) scientific observations and reflection; and 4) take-home family learning resources. Unit readings will include both: 1) a narrative (fiction) book with a nutrition component; and 2) an informational (nonfiction) book showcasing a scientist and/or a scientific principle. Units will include a mentor guide and information on connecting families with community food resources. We will: 1) develop and evaluate the LEARN Science program, utilizing latest educational best practices; 2) establish the NIH SEPA Library Academy, a professional development program (PDP) focused on mentoring and building self-efficacy among library staff to deliver LEARN Science across MS; and 3) disseminate LEARN Science across the MS public libraries. LEARN Science will strengthen ISE opportunities for children in K-2; improve science achievement of children; and ultimately has the potential to expand the number of children choosing STEM careers.

Public health relevance
Poor science achievement in childhood negatively impacts adult health, due to poor scientific literacy and reasoning. LEARN Science – Library Efforts to Advance Reading and Nutrition Science – is an informal life science and reading program through a nutrition science lens to improve science knowledge and science identity among children in kindergarten through second grade (K-2) in Mississippi using public libraries. LEARN Science leverages an opportunity for improved science achievement; improved understanding of the role of public libraries in both science and health education and promotion; and improved health of children – now and in the future – by empowering them to make food choices for chronic disease prevention through hands-on nutrition education.